Structure meets function for OATP1B1, a transporter involved in the uptake of endogenous and xenobiotic materials and drugs

Project summary
The polymorphic transporter OATP1B1 plays significant roles in the hepatic uptake and disposition of
endogenous molecules and drugs. Further, OATP1B1 is involved in numerous drug-drug interactions (DDIs) due
to its multispecificity. Despite decades of research, many factors related to the determinants of ligand binding,
transport mechanism and energetics, as well as the structure of this important transporter are unresolved. The
long-term goal is to characterize hepatic transport at the microscopic and macroscopic levels. Due to the
functional importance of OATP1B1 in liver clearance, this is the first target studied. The central hypothesis is that
structures of human OATP1B1 and functional assays performed on isolated proteins will unequivocally define
the mechanism of ligand binding, transport, and inhibition. The rationale that underlies this research is that
protein structures coupled with unambiguous, reproducible activity assays are absolutely required to fully
characterize the mechanism of transport and resolve long-standing conflicting data reported in the literature.
Establishing robust expression and purification protocols for human OATP1B1 facilitates pursuing the two
Specific Aims: 1) Resolve structures of OATP1B1 by Cryo-EM and analyze their motions by MD simulations. 2)
Functionally characterize the transport mechanism of OATP1B1. For the 1st Aim, the optimal conditions that
result in the highest image quality for Cryo-EM of OATP1B1 would be screened, and data would be acquired in
the presence and absence of ligands. The Cryo-EM studies will be augmented by MD simulations and docking
studies that would reveal details that are not accessible by mere structural analysis. The different biochemical
conditions (apo and holo) increase the likelihood of A) solving the structural determinants of the binding of various
ligands (with distinct chemistries) to the two ligand-binding sites of OATP1B1. B) solving the structures of multiple
conformations that are part of the transport cycle. For the 2nd Aim, we will use purified protein reconstituted into
proteoliposomes to characterize the inherent properties of OATP1B1 such as the energizing ion for transport,
the influence of the membrane voltage, and pH. Those results would be compared with cellular assays that
include intact cellular machinery, and other plasma membrane transporters that might directly or indirectly affect
OATP1B1. The research proposed in this application is innovative, in the applicant’s opinion because it
introduces two methodologies that have never been explored for any OATP isoform. These could uncover a
plethora of novel insights into the structure/function relationship of OATP1B1. The proposed research is
significant since OATP1B1 is involved in DDIs of several commonly prescribed drugs, sometimes resulting in
life-threatening situations. This study would unravel the exact determinants of ligand binding to OATP1B1 and
transport. Ultimately, the structural and functional knowledge generated here has the potential to aid in the design
of drugs that exhibit a lower propensity for DDIs.

Public health relevance
Project Narrative The proposed research is relevant to public health because it focuses on functional and mechanistic studies of a transport protein – OATP1B1 that is involved in the uptake of various endogenous molecules and drugs into hepatocytes, which is the first step in the process of drug processing in the liver. Due to the promiscuity of OATP1B1, various co-administered drugs could compete with each other, resulting in elevated plasma levels of the drugs, and risking adverse side effects. Also, some cancers overexpress OATP1B1 and it is the conduit through which anti-cancer medications or hormones that promote the growth of the cancers enter the cells. Thus, deciphering the structure and mechanism of OATP1B1 would advance our understanding of these processes, and aid in drug design that minimizes drug-drug interactions, which is relevant to the NIH’s mission.